2020 Conference on Regulating with RNA in Bacteria and Archaea (CRRBA)

Abstract A Conference on Regulating with RNA in Bacteria and Archaea (CRRBA) will occur September 7- 10, 2020 at the Hilton Bayfront Hotel in St. Petersburg, Florida. The mission of CRRBA is to convene an international community of researchers that does not normally associate with one another but that shares a common interest in studying the biology of bacterial RNAs. Noncoding RNAs have diverse functions in bacteria, including but not limited to acting as small regulatory RNAs, CRISPR systems, RNA thermometers, and ligand-sensing riboswitches. These noncoding RNAs regulate many bacterial properties, such as core metabolic pathways, pathogenesis, quorum sensing, antibiotic resistance and biofilm formation. By bringing together the researchers that study bacterial noncoding RNAs from different perspectives, the CRRBA will create new collaborations and lead to new scientific innovation. Between 200-300 attendees are anticipated, including many NIH-funded investigators. It features 9 sessions over four days that include but are not limited to the following: noncoding RNAs in infection biology, regulatory mechanisms of small RNAs, signaling nucleotides, CRISPR, interactions between RNAs and proteins, toxin-antitoxin systems and high-resolution structural analyses. Each session will feature an invited speaker followed by talks by young investigators, postdoctoral fellows, and graduate students drawn from the submitted abstracts. Two poster sessions will provide an additional opportunity for participants to discuss their work face-to-face. Half of the invited speakers and discussion chairs are women. To increase diversity of attendees at the meeting, we will send promotional information to diversity-based programs, such as those promoted on the NIH website. The CRRBA will also be publicized through diverse online strategies including a dedicated website, announcements at other meetings, extensive activity on Twitter, and on relevant email lists. In particular, the meeting will be advertised to the members of the RNA Society, which has a large international membership. The meeting will also feature a career development lunch where trainees can sit at tables alongside professionals from industry, academia, and government institutions. This unique mentoring lunch will allow students and postdocs to engage directly with scientists from a wide range of career perspectives. In summary, the CRRBA program will feature a remarkable itinerary of high-impact discoveries and help train the next generation of scientists.

Public health relevance
Narrative The purpose of the Conference on Regulating with RNA in Bacteria and Archaea (CRRBA) is to foster communication and collaboration between scientists studying the biology of noncoding RNAs in microbes. Through 9 sessions over four days the CRRBA will highlight high-impact discoveries of new noncoding RNAs, their molecular functions, and role in microbial physiology. The meeting will provide opportunities for early career scientists by featuring 32 short talks drawn from the submitted abstracts, as well as a Career Development Lunch.